Regulation of Cell Signaling by Human Biliverdin Reductase

DESCRIPTION (provided by applicant): Biliverdin reductase (BVR) is an evolutionary conserved protein, with an unmatched range of cellular functions. BVR is expressed to a varying degree in all tissues, the liver parenchyma cells are the primary site of its activity. As a reductase, it converts biliverdin which is a hepatotoxin and inhibitor of kinases and NF-:B, to the potent antioxidant, bilirubin. Biliverdin is a modulator of liver tumor cell growth, AhR ligand, and is elevated in carriers of BVR mutation with end-stage liver cirrhosis. Indeed, a compromised BVR activity causes green jaundice, which is nearly always fatal. We have shown, in addition to its reductase activity, BVR is a Ser/Thr/Tyr kinase, a cellular scaffold/bridge for MEK/ERK/Elk activation, a nuclear transporter of ERK1/2 and hematin, a leucine-zipper (bZip) transcription factor, a regulator of TNF-1- activated kinase-mediator of autoimmunity and activator of NF-:B. Demonstrated functions of BVR include regulation and/or activation of kinases in the insulin/IGF/MAPK/PI3K signaling pathways that regulate glucose uptake, cell growth, apoptosis and stress-response gene expression (c-fos, c-jun, HO-1, CREB/ATF- 2). The human (h)BVR is regulated by IGF-1 and is an activator of the signaling pathway downstream of the growth factor. The discovery that small BVR-based peptides can effectively intervene in the MAPK pathway at several key junctions is a highly relevant finding toward the development of novel therapeutic agents. Furthermore, transformed cells stably transfected with hBVR display a most striking differentiated morphology and growth in size. Gene array analysis suggested increases in EGFR and hBVR are linked; EGF is the regulator of STAT/JAK signaling. Notably, the hBVR promoter contains consensus sequences for binding STAT1 and Elk; and, in a yeast two-hybrid screening of high stringency, JAK2 kinase was identified as hBVR binding partner; hBVR, STAT1 and Elk are activated by cytokines. Presently, we hypothesize that BVR functions in defining cytoskeletal organization and regulation of cell cycle progression events that are mediated by growth factors. We further hypothesize that disruption of hBVR activity will protect liver damage induced by cytokines. To test these hypotheses: Specific Aim 1 will investigate hBVR function in cell signaling pathways that control cell growth/proliferation, differentiation and mobility in HepG2 cells stimulated by EGF. Specific Aim 2 will characterize hBVR promoter with focus on the potential regulatory loops with STAT1 and Elk. Specific Aim 3 will evaluate in primary rat hepatocytes and in ex vivo perfused rat liver protection by hBVR peptides against interferon-3-mediated toxicity. Impact: BVR is poised to occupy a key role in regulation of a wide range of cellular functions; therefore, BVR-based technology is a viable target for development of novel therapeutic approaches. We believe the outlined investigations most likely will stimulate new directions of investigation in the development of therapeutic targets that will have positive impact on public health. Findings with hBVR-peptides underscore the plausibility of this perception. PUBLIC HEALTH RELEVANCE: There are key juncture in the pathways that govern adaptive and protective regulatory mechanisms of the cell by relaying signals initiated at the cell membrane to the nucleus of the cell for generating appropriate response. Therefore, control of their activity is vital to maintenance of cellular integrity. In the recent years, we have discovered that the enzyme, biliverdin reductase, controls function of all key steps examined to date in the pathways that regulate response of the cell to insulin/insulin-like growth factor, oxidative stress and inflammatory agents. In addition, the enzyme activity is necessary for protection against the fatal green jaundice. Our work has revealed a novel approach for development of therapeutic interventions in a range of human diseases.

Public health relevance
Project Narrative There are key juncture in the pathways that govern adaptive and protective regulatory mechanisms of the cell by relaying signals initiated at the cell membrane to the nucleus of the cell for generating appropriate response. Therefore, control of their activity is vital to maintenance of cellular integrity. In the recent years, we have discovered that the enzyme, biliverdin reductase, controls function of all key steps examined to date in the pathways that regulate response of the cell to insulin/insulin-like growth factor, oxidative stress and inflammatory agents. In addition, the enzyme activity is necessary for protection against the fatal "green jaundice". Our work has revealed a novel approach for development of therapeutic interventions in a range of human diseases.